SOMATOSENSORY STUDIES OF PAIN AND PAIN CONTROL MEASURED WITH PET AND FMRI

The goal of this clinical research effort is to understand how the human central nervous system processes pain information and to identify abnormalities in CNS pain processing in patients with neuropathic and/or chronic pain conditions. High resolution (a) positron emission tomography (PET) with radioactive tracers or (b) functional magnetic resonance imaging (fMRI) techniques are used to assess regional brain activity via blood flow changes. These methods allow us to employ state of the art functional and structural brain imaging techniques to the study of normal and pathological pain states in human beings. Over the past year we have established our data analysis workstation and fully implemented several basic brain imaging analysis methodologies for PET data sets, and systems for data archiving. Oxygen-15 water blood flow PET studies were conducted on 15 normal volunteers and 14 patients with unilateral post-herpetic neuralgia. The major normal volunteer study involved a fully quantitative evaluation of regional cerebral blood flow during acute capsaicin induced pain. We discovered that capsaicin induced a massive decrease in global blood flow. This decrease (30%) could not be accounted for by changes in arterial pCO2, heart rate or respiratory rate. This pain induced decrease is a new and previously unreported alteration in cerebral blood flow induced by a physiological stimulus. It is rapid in onset, large in magnitude, transient in duration, and may represent a novel cerebrovascular regulatory mechanism evoked by strong acute pain. Our PET studies of chronic pain associated with post-herpetic neuralgia (PHN) suggest that pain induced from the neuropathic zone by a light tactile stimulus induces activity in a network of brain regions containing both nociceptive and non-nociceptive somatosensory components. These patients are elderly and control PET data from a group of age-matched normal subjects was obtained via collaboration with the Laboratory of Neurosciences, NIA. The multislice fMRI studies investigated the influence of increasing levels of activation on the spatial distribution of the fMRI signals. The data indicate that increasing levels of movement or noxious thermal stimulation result in increased signal intensity that retains its spatially discrete nature. Our data suggest that we can discriminate large versus small caliber vessels based on MR signal magnitude, although several alternative explanations need to be explored as well. MRI provides a powerful new tool for investigation of dynamic aspects of human pain and its disorders.